Health Disparities in Alzheimers and Related Diseases

This application from Florida International University (FIU) and Emory University requests support for a four-year
research conference series to address critical scientific issues associated with reducing Alzheimer's Disease
and Related Dementia (ADRD) inequities among ethnic minorities in the United States. The conference series
we propose rests on interdisciplinary research using a population disease framework, with specific attention to
ethnic groups and sex differences in pathways to neurodegenerative diseases. Genetics and family/personal
health histories are non-modifiable factors, and modifiable factors include a wide range of lifespan environmental
exposures and lifestyle factors. The conference series focuses on increasing understanding about how genetic
factors are operating in concert with environmental exposures, family and personal health histories, and lifestyle
factors to produce interactions that enhance or mitigate risk of ADRD within and between ethnic groups,
specifically among African Americans, Latinos, and non-Latino Whites. These critical issues remain largely
overlooked and are fundamental for increasing knowledge for disease modification using precision medicine and
for pharmacologic and non-pharmacologic intervention development in under-represented populations in AD
clinical trials. The 4 related specific aims of the series are: 1. To understand how the current evidence examines
specific genes, individually or in combination, are differentially distributed by ethnicity and sex, and are
associated with higher risk or protection against LOAD between and among higher risk ethnic groups. 2. To
describe how genetic risk may be modulated by factors such as epigenetics, age, sex, environmental exposures,
lifestyle/diet, family and personal health histories, social, and demographic factors between and within ethnic
groups and women at disproportionate risk for LOAD. 3. To examine current knowledge about how comorbidities
such as vascular diseases, diabetes, and mental health moderate or mediate the increase risk of ADRD in these
under-represented populations. 4. To explore underlying theory, new findings, and innovative observation,
instrument development and calibration for respondent or patient assessment, and measurement/analytic
strategies to improve our understanding of the gene x environment interactions influencing ADRD risk and how
methods may be modified or adapted for use in specific research applications with higher risk minority
populations and women.

Public health relevance
Narrative: This proposed 4-series Conference is highly relevant to public health issues related to Alzheimer's disease and related dementias (ADRD). The series will serve as a forum to bring together an interdisciplinary group of clinicians, scientists and the community to develop a population disease framework related to unique factors related to the susceptibility of minority populations to ADRD. Focus will include genetic, environmental, lifestyle and sociodemographic factors will the goal of understanding how genetic factors interact with these other factors to enhance risk of ADRD within and between minorities.